SoundScape: A portable small animal imager to accelerate drug development

SUMMARY
Drug development plays an invaluable role in bringing life-saving pharmaceuticals to patients, but the process is
slow and can take many years. Animal imaging plays a prominent role in the pre-clinical development phase
which can make up a significant portion of the timeline (5-10 years). A major factor that impacts the duration of
this phase is the high capital and recurrent costs of imaging lab equipment that limit the number of available labs
that participate in drug development.
While medical imaging is currently used for noninvasive, in vivo longitudinal small-animal studies, these studies
often require access to complex equipment, and dedicated personnel who are properly trained in their use, which
results in high costs. The most common current imaging modalities include Micro-CT, MRI, fluorescence
imaging, photoacoustic imaging and ultrasound. The first two methods provide high-resolution and are de-facto
standards, but they are expensive, non-portable, and require active shielding for ionizing radiation and magnetic
fields, respectively. Fluorescence imaging is commonly used to track tumor growth, but generally suffers from
poor resolution in deep tissue, and it requires external contrast agents. The emerging photoacoustic tomography
method offers cross-sectional 3D imaging, but at the expense of portability, increased cost, and reduced
reliability due to the usage of pulsed lasers. Traditional preclinical pulse-echo ultrasound is fast, portable, delivers
high (~30 μm) resolution and allows for vascular and blood flow imaging; however, the imaging results depend
strongly on the operator skills, and the images are limited to partial cross-sections of the animal that often do not
provide quantitative physical tissue characteristics.
There is therefore a need for more cost-effective imaging solutions with high image quality. As a first step in
fulfilling this need, the objective of our study is to design a small animal scanner that operates on the principles
of ultrasound tomography (UST), a novel technique for visualizing tissue properties with computed tomography
that uses sound waves instead of X-rays. Ultimately, we wish to develop the “SoundScape mini”, a commercial
product that will generate MRI-like images of small animals at a fraction of the cost of MRI, making it available
to the multitude of smaller labs that currently lack the resources to perform their own pre-clinical imaging. By
making pre-clinical imaging accessible to all labs, we seek to harness their collective power to crowdsource drug
development, thereby substantially shortening the pre-clinical development and testing phase. The system will
have the additional advantages of being desktop portable and fully automated without the need for a dedicated
technician.
In summary, we believe that any lab/investigator will be able to accommodate a SoundScape mini. Our long-
term goal is to empower a large scientific community with SoundScape, thereby greatly expanding the bandwidth
of drug development, accelerating time to market and generating substantial positive impact on global health.

Public health relevance
NARRATIVE Drug development plays an invaluable role in bringing life-saving pharmaceuticals to patients, but the process is slow and can take many years. Our approach to accelerate the process is to develop the “SoundScape mini”, a cost-effective imaging system that would help substantially shorten the pre-clinical development and testing phase of drug development for the multitude of smaller labs that currently lack the resources to perform their own pre-clinical imaging.